Demographic Distribution of Hand Joint Space

Project Summary/Abstract
Osteoarthritis (OA) is the most common form of arthritis and is prevalent in many joints, including
the joints of the hand. In order to increase the understanding of hand OA, it is necessary to
understand the natural structure of these joints. Radiography is commonly used in the scientific
and clinical evaluation which can include joint space width (JSW) measurement, which can
progressively decline due to cartilage deterioration. When considering demographics, these JSW
measures have the potential to be different, given the diversity of living conditions. With respect
to the hand, radiographic JSW is more easily discernable in the finger joints, as opposed to the
thumb; specifically, the thumb carpometacarpal joint (CMC), where the complex morphology can
render 2D visualization challenging. However, with computed tomography (CT), the joint can be
viewed in 3D and the JSW more readily assessed. With these factors to consider, the specific
aims of this project are: (1) Establish age-specific distribution percentiles for JSW in the finger
joints of African Americans and Whites, separately for men and women, for two time points, using
data from the Osteoarthritis Initiative (OAI); and (2) Establish reference values and demographic
distributions for the thumb CMC JSW using CT and evaluate the relationship with 2D radiographic
JSW measurement. Aim 1 will utilize data from the OAI for approximately 3500 hand radiographs.
These radiographs will be evaluated for JSW at two time points and separated by age, race and
gender. For Aim 2, a cohort of 25 males and 25 females will be recruited. A radiograph and CT
scan of each of the participant hands will be taken. 3D models will be constructed from the CT
images, from which CMC JSW measurements will be made and similar demographic information
will be drawn. The CT measurements will then be used to identify landmarks on the radiographic
images to make the 2D JSW measurement. Statistical comparisons will be drawn between the
two measurements and the results will be used in the formulation of novel relationships suitable
for adjusting the 2D measurements for agreement with the 3D measurements. Ultimately, this
work will result in the quantification of JSW for the entire hand. The longitudinal data for the finger
joints will support the goals of the parent project in the future development of predictive models
for OA development for at-risk populations. The framework developed for the thumb can be
expanded for a larger population for the development of similar predictive models. This project
supports the career development of the candidate by initiating research focused on the use of
engineering processes and medical imaging, for the development of computational models which
can be used to evaluate the mechanics of healthy and arthritic joints.

Public health relevance
Project Narrative Osteoarthritis is the most common form of arthritis affecting a large portion of the population and can be characterized by the loss of space between joints, resulting in pain and limitation of critical joint functions necessary for daily living. This research will quantify the joint space for the complete hand and validate 2D radiography with 3D computed tomography, increasing the knowledge base for joint space, which is a critical evaluation metric for the identification and monitoring of osteoarthritis. This knowledge can be used to understand the structural conditions of the hand, with respect to age, gender and race, allowing for improved qualitative and quantitative reference in the evaluation of osteoarthritis, thus, leading to more accurate diagnosis and joint-health evaluation for the entire population.